Spinning Disk Super Resolution Confocal Microscope for the Vanderbilt Brain Institute

PROJECT SUMMARY / ABSTRACT
Funds are requested to purchase a Nikon Spinning Disk Super Resolution (CSU-W1/SoRa) Confocal
microscope for imaging projects focused around mental health research within the Vanderbilt Brain Institute
(VBI), a multi-disciplinary research institute comprised of faculty at Vanderbilt University (VU) and Vanderbilt
University Medical Center (VUMC). The requested instrument will be integrated into and managed by the
Vanderbilt Cell Imaging Shared Resource (CISR), a microscopy core with a 20+ year history of successful
microscopy management, training, and acquisition of new technology. This instrument capable of confocal
imaging and super resolution imaging in live samples is ideal for 6 Major and 7 Minor Users within the VBI with
projects surrounding synaptogenesis, synapse assembly and plasticity, subsynaptic signaling, and
communication between cell and tissue populations. These molecular and cellular investigations will advance
already funded NIMH and NIH projects totaling over $6.8M in FY22 in the areas of social interaction, impulsive
aggression, learning and memory, Rett syndrome (RTT), ADHD, and more.
The proposed microscope configuration is based on the needs of the VBI and Major Users for live imaging at
cellular and subcellular resolution. The Nikon CSU-W1 SoRa confocal microscope includes: 1) CSU-W1
spinning disk plus Yokogawa SoRa super resolution spinning disk for super resolution near 120 nm in XY; 2)
stage-top incubation for imaging live cells and organoids; 3) Z-Piezo stage for increased speed in Z for 3D
volumes; 4) Hamamatsu Orca-Fusion sCMOS camera with 30-100 frames per second; 5) excitation lasers of
405, 488, 561, and 633 nm; and 6) objective lenses for live cell imaging at high resolution ranging from 10x, 20x,
40x, 60x, and 100x. This new system would be housed in existing CISR space in Medical Research Building III
(MRBIII) where the VBI is based and the majority of the Major User labs are located.
Vanderbilt University is providing financial support to promote the long-term operation of the instrument. If
awarded, the Office of the Dean of Basic Sciences is committed to providing $75,000 for CISR staff salary,
computer purchases and upgrades, and reduction in user fees over the first 5 years. Technical support and
training of new users will be facilitated by the exceptional staff within the CISR, which has a greater than 20-year
history of assisting over 300 labs on campus. Moreover, this equipment will become part of the Vanderbilt Nikon
Center of Excellence (COE) that is housed within the CISR. This CISR/Nikon COE provides a dedicated local
team of specialists to support the microscopy needs of investigators on campus. Collectively, the proposed
confocal system, together with outstanding institutional and core facility support, will enable the long-term
objective of supporting and advancing neuroscience and mental health research Vanderbilt.

Public health relevance
PROJECT NARRATIVE Confocal and super resolution microscopy are among the most prevalent techniques for imaging at subcellular resolution and imaging in live samples. The Nikon Spinning Disk Super Resolution (CSU-W1/SoRa) Confocal microscope will support research in the Vanderbilt Brain Institute among 6 Major User and 7 Minor User NIMH- and NIH-funded laboratories studying social interaction, impulsive aggression, learning and memory, Rett syndrome (RTT), ADHD, and other topics in the basic science of mental health. There exists a substantial and fundamental need for this state-of-the-art instrument to support the ongoing work of numerous NIMH- and NIH- sponsored investigators at Vanderbilt University and Vanderbilt University Medical Center.